University of Michigan BACPAC Mechanistic Research Center

Project Summary / Abstract
Individual and societal burdens from chronic low back pain (cLBP) are significant and associated with long
term functional impairment, disability, and poor quality of life. There are many efficacious treatments in cLBP
but the factors that predict treatment effectiveness in an individual are still not well understood. Treatments for
chronic pain include several pharmacologic (e.g., duloxetine and gabapentin) and non-pharmacologic
treatments such as physical therapy, acupressure, mindfulness-based interventions, and web-based self-
management programs. There is an urgent need for a greater understanding of pain mechanisms and
predictors of response to different therapies with a goal of matching patients based on phenotypes to therapies
to which they are most likely to respond. The parent award, a HEAL Initiative award (U19 AR076734), uses a
precision medicine approach to identify what treatments are likely to work in different patient endotypes. The
proposed supplement will allow me, a clinical rheumatologist, to learn these skills through assessments of
acupressure and the web-based self-management program on patient-reported pain in cLBP. Clinically
available data (such as patient-reported outcomes) as well as state-of-the-art phenotyping methods such as
functional MRI (fMRI) and Quantitative Sensory Testing (QST), will be available to mechanistically explore the
proposed neurobiological effects of these treatments. This knowledge will be invaluable in my future research
on evaluation of pain mechanisms and responsiveness to treatment based on phenotypes of individuals with
rheumatic disease.

Public health relevance
Project Narrative Chronic low back pain (cLBP) is a highly prevalent and often debilitating pain condition with several evidence- based therapies, although only a subset of individuals responds to each modality. A better understanding of pain mechanisms and how to predict response to different therapies is critical. The proposed supplement will allow the trainee, a clinical rheumatologist, to learn these skills through assessment of acupressure and digital interventions, standardized interventions on patient-reported pain in cLBP, and subsequently be able to study similar treatments in patients with autoimmune disease.